TR&D 1: Reimagining the Future of Scanning: Intelligent Image Acquisition, Reconstruction and Analysis

TRD1 Project Summary
The broad mission of our Center for Advanced Imaging Innovation and Research (CAI2R) is to bring together
collaborative translational research teams for the development of high-impact biomedical imaging
technologies, with the ultimate goal of changing day-to-day clinical practice. Technology Research and
Development (TRD) Project 1 aims to replace traditional complex and inefficient imaging protocols with simple,
comprehensive acquisitions that also yield quantitative parameters sensitive to specific disease processes.
Working with a diverse set of collaborators around the world, TRD1 investigators have made substantial
progress and significant contributions over the previous two funding periods since 2014. Building upon the
foundation established in the previous funding periods, we are now poised to expand TRD1 into exciting new
areas that we believe have the potential to help shape the future of rapid MRI. We will reimagine the process of
MR scanning, leveraging our core expertise in pulse-sequence design, parallel imaging, compressed sensing,
model-based image reconstruction and machine learning to enable intelligent quantification in MRI. We will
also diversify our rapid MRI methods to integrate multifaceted sampling schemes, such as spiral or rosette
trajectories, to achieve more efficient and effective sampling for new MRI applications such as low-field
imaging and diffusion imaging. Additionally, we will also explore a new area of rapid MRI exploiting longitudinal
image memory, with a focus on emerging new applications such as MR-guided radiotherapy and longitudinal
disease monitoring. These new developments will be closely connected with the other two TRDs and will
provide key enabling technologies to our CPs and SPs. Successful completion of the projects proposed in
TRD1 will result in new MRI techniques that enable rapid and multifaced data acquisition, as well as more
intelligent image reconstruction, quantification and interpretation. These techniques, in turn, will help advance
imaging research and enhance patient care.